Release of Extracellular DNA during Biofilm Formation in Staphylococcus aureus

Staphylococcus aureus is often the cause of nosocomial infections, particularly when
these infections involve bacterial colonization of indwelling devices. The fact that these bacteria
are frequently carried asymptomatically on the skin and mucosal surfaces of many individuals
permits easy colonization of the pristine surfaces of such devices during implantation. Once
biofilms grow on these surfaces, they are difficult to eradicate because the constituent cells
become largely insensitive to the action of many commonly used antibiotics. These findings,
combined with the fact that a large percentage of S. aureus isolates identified in infections are
now resistant to numerous antibiotics makes it clear that new ways of combating staphylococcal
biofilm-associated infections need to be developed. The goal of this project is to understand
how methicillin-resistant S. aureus (MRSA) forms biofilms and thereby identify targets for the
discovery of drugs that block or reverse the formation of surface-associated communities.
To form a biofilm, S. aureus must produce an extracellular matrix. Major components of
the matrix are proteins and DNA. Many of the proteins are cytoplasmic in origin and are thus
moonlighting in their second role as components of the matrix. The extracellular DNA requires
the matrix proteins in order to adhere to the cells, serving as an electrostatic net that holds the
remaining cells together in the biofilm. Using a comprehensive molecular genetic approach, we
identified genes needed for the release of extracellular DNA during biofilm formation, including
the gene for a phosphodiesterase that controls the levels of a well-known second messenger,
cyclic-di-AMP. We have shown that cyclic-di-AMP levels drop when cells enter the biofilm state.
We propose to take advantage of a biosensor for measuring cyclic-di-AMP levels in cells
to identify genes that control its levels as cells enter the biofilm state. We will take advantage of
the discovery that mutants with altered levels of the second messenger are resistant to the dye
Congo red to discover additional genes involved in controlling cyclic-di-AMP levels.
We propose that the drop in cyclic-di-AMP levels weakens the cell envelope, causing
some cells to lyse and liberate protein and DNA for incorporation into the matrix. We will
investigate the hypothesis that low cyclic-di-AMP levels impair proper biosynthesis of teichoic
acid, the cell envelope polymers needed for cell wall integrity.
Finally, we exploit our fluorescent assay for c-di-AMP to carry out a cell-based screen for
small molecules that cause levels of the second messenger to rise. These hits will be a starting
point for the development of drugs that block biofilm formation.

Public health relevance
The bacterial pathogen Staphylococcus aureus is a leading cause of multi-antibiotic-resistant nosocomial infections and is often found growing as a biofilm in catheters and chronic wounds. Biofilms are communities in which the cells are held together by an extracellular matrix consisting of protein, polysaccharide and DNA. Here we investigate how S. aureus cells enter the biofilm state and seek to identify small molecules that inhibit formation of these surface-associated communities.